Establishment of a Bat Resource for Infectious Disease Research

Project Summary / Abstract
Bats are reservoirs, or suspected reservoirs, of many zoonotic viruses, including SARS, SARS2 and MERS
coronaviruses, Nipah and Hendra viruses, and Ebola and Marburg viruses. Little is known about how these
viruses circulate in their bat reservoirs, principally because of a lack of bat colonies that can be used for the
development of experimental infection models. To address this deficiency, we will capture horseshoe bats and
Indian flying foxes, respective reservoir hosts of Nipah virus and SARS-related coronaviruses, in Bangladesh
where they will be quarantined and provided veterinary care as they adapt to captivity. Bats will be shipped to
CSU to establish the breeding colonies as a resource for investigators who study these viruses. We will generate
primary cell cultures and immortalized cell lines from various tissues and freeze live bone marrow that will be
useful for studying how these viruses infect bat cells, and how the viruses may modulate the innate immune
responses. Recombinant cytokines will also be produced for the research community, including those for
generating macrophages and dendritic cells (GM-CSF, Flt3L), T cells (IL-2) and for in vivo modulation of the
adaptive immune response (IFN, IL-4). Moreover, we will generate monoclonal antibodies for use in cytokine
detection assays and flow cytometry of immune cell subsets and in vivo neutralization. Finally, we will perform
experimental infection studies of Nipah virus, SARS-CoV-2 and the SARS-related coronavirus, RaTG13, to study
the infection kinetics, virus distribution and transcriptomic, proteomic and metabolomic profiles of bats during
infection, and escalation and resolution of the immune response. Tissues, cells and sera from naïve and infected
bats will be archived in a biobank that will be made available to the research community. The establishment of
this resource will lead to a better understanding of how bats host highly pathogenic viruses without disease and
may shed light on events that increase spillover risks to humans. In turn, this information could lead to
development of mitigation strategies to prevent future virus spillover and uncover new strategies for therapeutic
treatment of coronavirus and Nipah virus diseases.

Public health relevance
Project Narrative Bats are reservoirs of several human pathogenic viruses with pandemic potential, including coronaviruses and henipaviruses. Currently, there are no closed breeding colonies of bats that host these viruses, thus, it is difficult to study the viruses in their natural reservoir hosts. We will establish breeding colonies of horseshoe bats and Indian flying foxes to provide bats, cells and reagents for researchers who study SARS-related coronaviruses and Nipah virus.